National Consortium on Alcohol and NeuroDevelopment in Adolescence (NCANDA): Administrative Resource

PROJECT SUMMARY
Excessive alcohol drinking Initiated during adolescence is known to disturb typical neurodevelopmental patterns,
increase the risk of developing alcohol use disorder (AUD), and accelerate involutional processes in adulthood.
In response to RFA-AA-21-008, the Administrative Resource (AR) proposes to coordinate activities of the
National Consortium on Alcohol and Neurodevelopment in Adolescence - Adulthood (NCANDA-A) to follow for
the next 5 years a diverse community sample of male and female participants recruited in three age bands (12-
14, 15-17, 18-21 years old) as mostly no-to-low drinkers, tracked over the last 8 years across 5 sites (N=831;
93% retention rate). This consortium reflects seven applications: NCANDA - Administrative Resource (UCSD)
and NCANDA - Data Analysis Resource (SRI), and five cross-national Research Project Sites, located at Duke
University (Duke), Oregon Health Science University (OHSU), University of Pittsburgh (Pitt), SRI International
(SRI), and UC San Diego (UCSD). Monitoring has involved annually multimodal neuroimaging (MRI, DTI, resting
state fMRI, task fMRI), cognitive, clinical, behavioral, and biological data, collected in person or remotely by
computer and our mobile app. These measures will now be complemented with new advanced neuroimaging
and sleep and physical activity tracking. Our accelerated longitudinal design uniquely positions NCANDA-A
(ages 18-34) to quantify transient or enduring alcohol-related disturbances in adolescent and early adult neural
system growth trajectories and functional concomitants.
NCANDA-A proposes four consortium-wide specific aims and two specialty project aims. In Aim 1, we investigate
the impact of excessive alcohol drinking during adolescence and emerging adulthood on subsequent
developmental trajectories of cognitive performance, brain structure and function, and psychopathology. Aim 2
identifies the extent to which alcohol’s effects on brain structure and function resolve or persist during desistance
of binge drinking. Aim 3 identifies adolescent biological, environmental, and behavioral factors that forecast
excessive drinking during early adulthood. Aim 4 quantifies COVID-19 pandemic impact on alcohol use, stress,
and wellbeing. Aim 5 (SRI and Pittsburgh sites) identifies interactions among alcohol use, sleep, and cardiac
function. Aim 6 (UCSD, Duke and OHSU sites) determines the extent to which short-term (i.e., 4 weeks) alcohol
use discontinuation results in acute improvement in cognition, affect, sleep and resting heart rate, and reversal
of structural and functional brain effects of binge alcohol use. For each aim, sex differences will be tested.
With longitudinal data collected into early adulthood during this renewal, NCANDA-A will provide novel
information on the enduring and transient effects of adolescent drinking on adult functioning by discovering
elements and mechanisms linking these dynamic processes and identifying modifiable risk factors.

Public health relevance
PROJECT NARRATIVE Heavy alcohol drinking during adolescence is known to disturb brain development and functioning and increase risk of drinking problems in adulthood, but the extent of the lingering effects of youthful drinking on adult functioning remains unclear. The goal of NCANDA-A (Adulthood) is to follow youth who had remained no-to-low drinkers compared with those who had engaged in hazardous drinking to determine alcohol's influence on cognitive, emotional, and life activities in emerging adulthood when young men and women are establishing themselves in careers, relationships, and independent living. Recognition of signs of risk to adjustment in adulthood following youthful drinking may enhance opportunity for personal success.